Heme-Based Immune Dysregulation in Critical Illness

PROJECT ABSTRACT
This NIGMS MIRA will support an Early Stage Investigator and help bridge the widening gap between
cutting-edge research and improving patient care in the field of hematology-immunology-infectious diseases,
through the investigation of heme dysregulation of the innate and adaptive immune system in patients with sepsis
or chronic hemolytic diseases ± red blood cell (RBC) transfusion as a function of circulating heme availability.
Sepsis is an invasive infectious disease associated with dysregulated systemic inflammation and more
than 4 million deaths worldwide per annum. Specific targeted therapies are lacking. Likewise, in chronic
hemolytic diseases such as Sickle Cell Disease (SCD) and Thalassemia, > 50,000 patients have died over the
past twenty years. Many patients (~50% in sepsis and >80% in chronic hemolytic diseases) receive a RBC
transfusion as supportive therapy or have ongoing ‘low levels’ of intravascular hemolysis. Recent evidence from
our laboratory indicate that this hemolysis may further disrupt a patient’s immune system and lead to worse
outcomes. This disruption may be causally linked to release of free heme from the underlying hemolysis. We
have recently shown that repetitive heme exposure may tolerize the innate and adaptive immune response
rendering the host immunosuppressed, which may explain why these patients are at high risk for infection.
This proposal will explore a causal relationship in human samples between dysregulated plasma heme
metabolism in states of hemolysis (both acute and chronic) and after RBC transfusion that lead to altered host
immunity (potentially via TLR4 binding or co-stimulation), further exacerbate inflammation, and worsen
outcomes. Program 1 will establish new understandings on relevant heme binding capacity and affinity during
critical illness and homeostasis. This overarching goal will define the effects of heme trafficking in plasma from
RBC transfusion in sepsis in comparison to chronic hemolytic diseases (hemoglobinopathies) by further refining
how binding protein-affinity for heme are affected by conditions of stress (sepsis, transfusion) compared to
homeostatic conditions. Second, we hope to further characterize how heme circulates in plasma with differing
binding molecules and whether this binding affect direct activation or suppression of canonical innate and
adaptive host immunologic pathways (Program 2). Finally, our program will develop new strategies in humans
(ex vivo) to scavenge circulating heme or block relevant molecular heme-immune pathways to mitigate negative
immune alterations.
Collectively, the PI, as an Early-Stage Investigator under this NIGMS MIRA, will close major gaps in
knowledge in heme metabolism and its impact on immune activation, providing key insights into acute and
chronic effects resulting from exposure to circulating heme in sepsis, SCD, critical illness, or after RBC
transfusion. The mechanistic understandings gained from these studies will help develop novel therapeutics to
minimize the morbidity and mortality of at-risk patients.

Public health relevance
PROJECT NARRATIVE This NIGMS MIRA ESI Program proposal will support this early-career physician-scientist and help bridge the widening gap between innovative research and improving patient care in the field of hematology-immunology- infectious diseases, through the investigation of heme dysregulation of the innate and adaptive immune system in patients with sepsis or chronic hemolytic diseases as a function of circulating heme availability. This proposal will explore a causal relationship between heme-protein binding, quantity and exposure of available circulating heme, and their potential for dysregulated plasma heme metabolism on host immunity (potentially via TLR4 binding or co-stimulation) that may further exacerbate inflammation and worsen outcomes in states of hemolysis (both acute and chronic) and after red blood cell transfusion. Collectively, the proposed program conducted in humans will provide key insights for a current gap in knowledge that will contribute to our understanding of how heme metabolism and potentially acute or chronic circulating heme exposure in sepsis, sickle cell disease, trauma, or after RBC transfusion may directly modulate immunity.